Role of membrane-associated macrophages in health and inflammation

PROJECT SUMMARY/ ABSTRACT
Mesenteritis is an inflammatory disorder of mesenteric tissues. It includes mesenteric
lipodystrophy (mesenteric fat necrosis), mesenteric panniculitis (chronic mesenteric fibrosis) and
mesenteric lymphadentis (mesenteric lymph node inflammation). It is diagnosed by an abdominal
computed tomography (CT) scan; however, the cause of mesenteritis remains unknown.
Emerging clinical evidence shows that mesenteritis is associated with gut inflammation such as
IBD and Chron's Disease. As innate myeloid cells, macrophages are distributed throughout the
whole organism and they play crucial roles in mediating tissue inflammation. Based on our
supporting data, we identified macrophage populations in serous membrane of gut mesentery
(termed membrane-associated macrophages). Thus, this research proposal seeks to address
fundamental questions regarding the tissue specific role of membrane-associated macrophages
in steady state and during mesenteritis induced gut inflammation. These include how membrane-
associated macrophages are reprogrammed by local niches and gut inflammation. To better
describe the role of these macrophages and its mechanism, we performed genetic studies of
membrane-associated macrophages that provided insight into their roles in steady state and gut
inflammation. These preliminary data results have led us to pursue to the following specific aims:
(1) Determine distinct homeostatic functions of membrane-associated macrophages and
local signals that shape their tissue specification; (2) Determine the role of membrane-
associated macrophages during mesenteritis induced by gut inflammation. We will perform
lineage tracing, cell ablation, transcriptomic analysis of membrane-associated macrophages and
in vivo live imaging to understand the role and dynamic interactions of macrophages with local
environment in steady state and during mesenteritis induced by gut inflammation. Ultimately, we
hope our studies will lead to the discovery of therapeutic targets to prevent mesenteritis as well
as gut inflammation.

Public health relevance
PROJECT NARRATIVE Mesenteritis is an inflammatory disease of gut mesentery; however, its cause remains unknown. We will assess the role of macrophages which reside in serous membrane of gut mesentery and their mechanism in mediating mesenteritis induced by gut inflammation. Our findings will increase our understanding of the role of membrane-associated macrophages during mesenteritis and potentially lead to the development of treatment for mesenteritis associated with gut inflammation.